DYNAMIC EXCHANGE BETWEEN CONFORMERS STUDIED BY 2D ELDOR ESR

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This project is an extension of our previous one dimension CW SRLS fitting program with dynamic exchange. It will enable a more accurate determination of the dynamic parameters related to the dynamic exchange processes, as 2D ELDOR ESR contains more spectral resolution and information than its 1D CW counterpart. We started from the MOMD version and will proceed to the SRLS version.